CONFIRMATION OF CANCER AND CAUSE OF DEATH

A. ROLE OF CORE This core serves each of the four projects by providing accurate and detailed information on cancer incidence and mortality. In addition, Projects 1, 2 and 3 are specifically served through the collection of the biopsy specimens from confirmed cases.